American Urological Association (AUA) Basic Science Symposium (BSS) on Spatial Biology in Benign and Malignant Urologic Disease

2024 AUA OFFICE OF RESEARCH BASIC SCIENCES SYMPOSIUM
“Spatial Biology in Benign and Malignant Urologic Disease”
PROJECT SUMMARY/ABSTRACT
This application requests support for our annual Basic Sciences Symposium during the Annual Meeting of
the American Urological Association (AUA), to be held on Saturday, May 4, 2024, 8:00 am – 12:00 pm in
San Antonio, TX. The 2024 topic, “Spatial Biology in Benign and Malignant Urologic Disease,” will bring
together pioneers in spatial biology to educate and foster interaction between urologists, other physicians,
and researchers who manage and/or study benign and malignant urological disorders. Recent advances in
spatial epigenomics are providing new insights into epigenetic priming, differentiation, and gene regulation
with implications for tumor staging and grading in urologic disease.
The symposium will bring the latest research advancements in spatial biology in urology to the world’s
largest gathering of national and international, private and academic practice, and physician scientists and
researchers at all career stages as well as have immediate applicability to malignant urology research.
Early-career investigators will comprise a significant proportion of the symposium presenters and audience
and the poster session will provide additional scientific discourse.
Proposed session topics include:
1. Spatial Transcriptomics/Epigenomics Technology
2. Spatial Biology and the Body
3. Patient Perspectives
The Principal Investigator for this project is Christine Riordan, PhD, LCSW-C, AUA Director of Research, and
the Program Chairs are David B. Solit, MD, Director, Memorial Sloan Kettering Cancer Center, and Douglas
Strand, PhD: Associate Professor of Urology, UT Southwestern Medical Center.
The Program Chairs prioritized consideration of racial, ethnic, gender/gender identity, sexual orientation,
nationality, cultural, religious, age, (dis)ability, career stage, and socioeconomic backgrounds in
accordance with the Diversity, Equity, and Inclusion Statement of the Research Education Conferences,
and Communications Committee (RECCC). Support for this symposium will provide travel awards for
approximately 20 trainees and early-career investigators.

Public health relevance
2024 AUA OFFICE OF RESEARCH BASIC SCIENCES SYMPOSIUM “Spatial Biology in Benign and Malignant Urologic Disease” PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT Understanding spatial biology in benign and malignant urologic disease is crucial to advancing urologic research and improving clinical care, and it is essential that the urology community, especially trainees, early- career physician-scientists, and researchers be provided with accessible opportunities to gain understanding of new knowledge and significant recent advances in these fields and leverage it towards improvements for patient diagnosis and treatment. The goal of the 2024 AUA Basic Sciences Symposium is to bring together pioneers in spatial biology to educate and foster interaction between urologists, other physicians, and researchers to provide new insights into epigenetic priming, differentiation, and gene regulation with implications for tumor staging and grading in urologic disease. The uniqueness of the 2024 Basic Sciences Symposium at the AUA Annual Meeting is not only that it brings the latest advancements in research to the world’s largest gathering of urologists and urology researchers, but also that the Program Chairs prioritized consideration of racial, ethnic, gender/gender identity, sexual orientation, nationality, cultural, religious, age, (dis)ability, career stage, and socioeconomic backgrounds in accordance with the Diversity, Equity, and Inclusion Statement of the AUA Office of Research: Research Education Conferences, and Communications Committee (RECCC).